Training Researchers in Clinical Integrative Medicine (TRIM)

PROJECT SUMMARY/ABSTRACT
Integrative medicine, including meditation, yoga, tai chi, massage, and other modalities are widely used by
Americans in the hope of obtaining health benefits. Evidence for the health effects of these practices, however,
has important limitations. The goal of the “Training for Research in Integrative Medicine” (TRIM) fellowship is to
train outstanding pre- and postdoctoral behavioral and social scientists, physicians, and other qualified health
professionals to design and conduct rigorous clinical and translational research in preparation for research
careers in integrative medicine. The program has four postdoctoral positions and two predoctoral positions.
The UCSF Osher Center for Integrative Medicine provides an exceptional context in which to offer the
program, and TRIM is designed to leverage the extensive training opportunities available as a result of being
embedded in the rich UCSF research environment. Since its inception 14 years ago, TRIM has maintained a
record of attracting extremely well qualified candidates who collectively have had a substantial impact on the
field of integrative medicine research. Nine of 20 post-doctoral fellows who have completed training have gone
on to receive K career development awards. The TRIM program provides an interdisciplinary clinical and
research environment; strong mentoring by an experienced research faculty; advanced training in clinical,
biological, and psychological research methodologies; special attention to research methodology issues that
are particularly relevant to integrative medicine research; extensive training in methods to enhance
reproducibility in research; opportunities to conduct original research; training in research ethics; and exposure
to diverse integrative approaches to patient care involving all age groups from early childhood through old
age. The interprofessional TRIM faculty is strongly committed to mentoring and has 11 core and 10 affiliated
members representing internal medicine, family medicine, psychology, neuroscience, molecular biology,
anthropology, biostatistics, psychoneuroendocrinology, women's health, pediatrics, health services research,
medical ethics, and psychiatry. A major strength of the training program is the clinical advisory faculty who are
available to provide technical assistance and consultation on specific integrative medicine approaches that
trainees might want to study. TRIM faculty provide expert and comprehensive mentoring, as well as required
and optional academic activities that are tailored to each trainee's individual learning objectives. New
curriculum components include a greater emphasis on social determinants of health. The program is strongly
committed to addressing issues of health equity and diversity, equity, and inclusion among its faculty and
trainees; as one metric, 43% of pre-doctoral fellows since the last renewal are underrepresented minorities in
medicine. The TRIM program provides research training and career development opportunities that will equip a
new generation of researchers to expand our knowledge-base of whether and how integrative medicine
approaches work for specific health conditions.

Public health relevance
PROJECT NARRATIVE Integrative Medicine modalities that may improve health, including meditation, yoga, tai chi, acupuncture, and massage, are widely used by Americans. Evidence for the health effects of these practices, however, has important limitations. This T32 grant will train outstanding pre- and postdoctoral scientists to perform well- designed research on integrative medicine approaches, and the training program will prepare a new generation of researchers to expand our understanding of whether and how integrative medicine approaches work for specific health conditions.